Regulation of Mechanical Coupling in Aging Myocardium

Project Summary
Age modifies heart structure and function, even in the absence of overt cardiovascular
disease. With age-related cardiac remodeling, the heart undergoes extensive cellular
and molecular changes that result in a stiffer less compliant heart that experiences an
overall decline in function. Yet, the human heart is capable of functioning for decades
despite minimal cell turnover or regeneration, suggesting that some mechanisms of
age-related cardiac remodeling may be compensatory and beneficial, helping sustain
heart function over our life span. Recent evidence indicates the upregulation of
cytoskeletal proteins may represent a cardioprotective mechanism in the aging heart. In
this exploratory R21 proposal, we hypothesize that enhancing the cytoskeletal
connection between N-cadherin and the cortical actin network represents an essential
compensatory mechanism to maintain force transmission in the aging mammalian heart.
To test this hypothesis, the regulation of vinculin, a force-sensitive cytoskeletal protein,
will be investigated during cardiac aging in mice. The following interrelated aims are
proposed: (1) To test the hypothesis that Abl kinase is required to maintain mechano-
electrical integrity in the aging heart. (2) To test the hypothesis that inhibition of tyrosine
phosphorylation of vinculin will perturb N-cadherin-cytoskeletal connection leading to
accelerated cardiac aging. The proposed studies will allow mechanistic insight into how
the major predisposing factor in heart disease, age, affects the remodeling of N-
cadherin junctions and mechanical coupling in the aging heart.

Public health relevance
Project Narrative: Successful completion of this project will enhance our understanding of the impact of cardiac aging on the N-cadherin-catenin-vinculin-actin mechanotransduction pathway, which will facilitate the design of novel therapeutic strategies to prevent adverse cardiac aging in healthy patients, and to improve function in heart failure patients.